Seronegative Autoimmune Encephalopathies: Biomarker Discovery, Validation & Deep Phenotyping

PROJECT SUMMARY
Incidence of autoimmune encephalitis exceeds that of infectious cause, but 50% percent (half of approximate
4000/year in the US) are IgG biomarker negative. Seronegativity hinders diagnosis and pathophysiologic
understanding in autoimmune encephalopathies (encephalitis, cerebellar ataxias and other movement
disorders). Novel IgG characterization, which attempts to address this gap, is linear and slow occurring at a
rate of 1-2 year (using standard tissue-based immunofluorescence assay [IFA] followed by western blots,
immunoprecipitation, and mass spectrometry). The long-term goal is to molecularly, clinically and
mechanistically characterize autoimmune encephalopathies, and develop targeted autoimmune therapies. The
overall objectives in this application, are to: 1) identify disease-specific biomarkers for seronegative
autoimmune encephalopathies; 2) molecularly validate novel biomarkers, and 3) clinically, radiologically and
immunologically deep-phenotype autoimmune encephalopathies. The central hypothesis is that seronegative
autoimmune encephalopathies are characterizable though biomarker discovery. The rationale for this project is
that biomarker discovery and translation could occur expeditiously, by leveraging complementary techniques in
parallel, that novel biomarkers could be molecularly validated, and that disorders associated with new
biomarkers could be neurologically and immunologically deep-phenotyped. To test the central hypothesis the
following three specific aims will be pursued: 1) Identify novel biomarkers, initially in 3 partly characterized
seronegative autoimmune encephalopathies; 2) determine validity of novel biomarkers; and 3) assess for
differentiated clinical phenotypes, and cytokine profile accompaniments. Under the first aim, serum and CSF
from seronegative autoimmune encephalopathy patients will be interrogated for neural antibodies using native
full-length protein microarrays, as principle technique, complemented by tissue and cell-based IFA for initial
IgG screening, and, as needed, phage immunoprecipitation sequencing, and mass spectrometry techniques
for verification. For the second aim, newly characterized IgGs will be validated in autoimmune encephalopathy
patients and controls by multiple antigen-specific methods (confocal indirect immunofluorescence, and
recombinant protein assays [western blot, cDNA-transfected cell-based]). For the third aim, patients with
autoimmune encephalopathies with characterized and validated neural IgGs will be deep-phenotyped clinically,
radiologically and immunologically, by evaluating for IgG effects in live neuron assays, and cytokine-chemokine
profiles. Remaining seronegative cohorts will be immunologically profiled by cytokine-chemokine assays. The
research proposed is innovative in the applicant’s opinion, as it focuses on multiplexed biomarker identification,
validation, and deep phenotyping. The proposed research is significant because disease-specific biomarkers,
with in-depth characterization, allow earlier diagnosis and treatment, and support disease mechanism studies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on characterizing poorly understood brain diseases caused by the immune system, known as autoimmune encephalopathies, through identification and validation of new antibodies as disease biomarkers. Once this work has been completed, these biomarkers have the potential to be informative in clinical practice for early diagnosis and immune treatment decisions, and disease mechanism research. Thus, the proposed research is relevant to the part of the NIH's mission that pertains to reducing illness and disability.